CD38 signaling in aging-associated immune responses induced by oral pathogens

The aging population has increased globally, leading to an increased incidence of aging-related comorbidities
including periodontitis. Our long-term goal is to develop effective new therapies to alleviate periodontal
inflammatory bone loss associated with aging-related periodontitis and help prolong the healthspan of human
beings. It is well-known that nicotinamide adenine dinucleotide (NAD+) plays essential roles in the healthspan of
human beings. Previous studies demonstrated that a decline of NAD+ in the aged population contributes to the
pathogenesis of various aging-associated diseases, including type II diabetes and Alzheimer’s disease.
Moreover, CD38 (an inflammatory marker and an enzyme active in degrading NAD+) enhanced in the aged
population. Inhibition of CD38 by a specific inhibitor (78c) reversed age-related NAD+ decline and increased the
lifespan and healthspan of naturally aged mice. However, significant knowledge gaps exist. It is unclear how oral
bacterial pathogens influence aging-associated immune responses, and how the CD38 signaling pathway
regulates aging-associated immune responses induced by oral bacterial pathogens. The goal of this application
is to define how oral pathogens affect aging-associated immune responses and whether inhibition of CD38 can
attenuate inflammatory bone loss and alleviate aging-associated immune responses induced by oral pathogens.
Our preliminary results are the first to show that the oral pathogen Aggregatibacter actinomycetemcomitans (Aa)
or Porphyromonas gingivalis (Pg), enhanced CD38 levels and significantly decreased the NAD+ levels in old
murine bone marrow-derived monocyte and macrophages (BMMs), compared with control levels derived from
young murine BMMs. Moreover, inhibition of CD38 by 78c reduced CD38 levels and reversed the decline of
NAD+ in murine BMMs infected with Aa. Additionally, in murine BMMs infected with Aa, treatment with 78c
enhanced the mRNA and protein levels of pro-longevity genes (Sirtuin1, PARP-1, and NAMPT) and superoxide
dismutase1 (SOD1, an antioxidant enzyme), but reduced NADPH oxidase1 (Nox1) expression. Furthermore,
treatment with 78c attenuated IL-1b, IL-6, and TNF-a cytokine levels induced by Aa and inhibited
osteoclastogenesis induced by RANKL. Thus, we hypothesize that inhibition of CD38 by 78c is a novel
therapeutic strategy to treat aging-associated periodontitis. Our specific aims are as follows: 1) We will
determine if murine BMMs derived from old mice have higher levels of CD38 and lower levels of NAD+ with or
without Aa or Pg infection, when compared with the murine BMMs derived from young mice, and if knockdown
or inhibition of CD38 in vitro in BMMs can reduce CD38, increase NAD+ and NAD+ biosynthesis salvage pathway
(Sirtin1, PARP-1, NAMPT) signaling, and reduce oxidative stress induced by Aa or Pg. 2) We will generate a
periodontitis animal model in mice, and determine if treatment with the CD38 specific inhibitor (78c) in vivo can
reduce CD38, attenuate periodontal inflammatory bone loss, decrease oxidative stress, enhance NAD+, and
increase Sirtin1, PARP-1, NAMPT genes in the tissues, compared with controls.

Public health relevance
Narrative CD38, an enzyme active in degrading nicotinamide adenine dinucleotide (NAD+), enhanced in the aged population, which results in a decline of NAD+ in the aged population, contributing to many aging-associated diseases, including type II diabetes and Alzheimer’s disease. This study determine if inhibition of CD38 can serve as a novel therapeutic strategy to treat aged patients with periodontitis to inhibit periodontal inflammatory bone loss, enhance NAD+ level, and promote genes associated with pro-longevity.